Prenatal Genetic Diagnosis by Genomic Sequencing: A Prospective Evaluation

Project Summary
This proposal will perform a clinical, technical, and behavioral evaluation of Genome Sequencing (GS) to
identify genetic conditions such as single gene disorders in apparently normal pregnancies as a routine addition
to prenatal diagnostic testing. Women between 10- and 24-weeks’ gestation planning prenatal diagnosis for
routine indications will be offered the opportunity to have GS performed in addition to the present standard of
karyotype and chromosomal microarray. American College of Medical Genetics (ACMG) defined pathologic,
and likely pathologic variants associated with severe and profound childhood disorders or those in which
treatment or modification of care up to age 8 will be reported to enrolled families. Variants of uncertain
significance meeting study criteria will be reported to parents when requested. Maternal genomic disorders
with the potential to alter pregnancy, delivery or postpartum health or care will also be reported. Parents will
complete psychosocial surveys prior to receiving results, after result reporting, and at one year post delivery.
Parents declining sequencing will also be surveyed. Infant health will be evaluated at 1 year of age or sooner
if positive results are reported. The primary outcomes will be the frequency of fetal and maternal reportable
disorders by either standard of care testing or GS testing and the incremental increase and benefit of reportable
disorders by GS. Parental psychosocial and behavioral characteristics of families undergoing GS will be
compared to a similar population of unsequenced pregnancies. They will also be compared to patients who
pursued sequencing in the setting of fetal anomalies. Using results from this study and those from our initial
study sequencing anomalous pregnancies, improved techniques for routine fetal phenotype and genotype
collection, aggregation, and sharing will be developed.

Public health relevance
Project Narrative Genetic conditions occur in approximately 1 in 50 people; many of them individually rare but overall, they affect over 2.8 million children between the ages of 0 to 7. Advances in genomics and Precision Medicine now illustrate the importance of diagnosing these disorders and initiating treatment as early in life as possible. This project will evaluate the ability to diagnose these disorders early in pregnancy to maximize treatment options.